Computational Modeling of Uteroplacental Hemodynamics

PROJECT SUMMARY
During early pregnancy, the maternal uterine vasculature, particularly the spiral arteries, must undergo significant
remodeling to establish uteroplacental circulation and create a hemodynamic environment suitable for placental
and fetal development. Defective or incomplete spiral artery remodeling has been reported as a common
characteristic of severe pregnancy disorders related to abnormal placental formation. Despite their importance,
the mechanistic links between uteroplacental hemodynamics and placentation and their implications in fetal
development have not been fully elucidated. Given the limitations of current technology to obtain in vivo data in
the early stages of pregnancy, computational models provide a promising approach to investigate mechanisms
of placentation and identify metrics for early diagnosis of pregnancy complications. Although models have
already been proposed to study this process, they are not without limitations. Our preliminary data have shown
that uncertainties related to placental anatomy and physiology can substantially affect simulation results. In
addition, the effect of blood rheology or other assumptions related to uterine vascular remodeling and mechanical
properties of the placenta and its vascular structures could significantly change local hemodynamics in this
organ. Therefore, a systematic analysis of the effect of these factors to establish a robust platform to study
pregnancy hemodynamics and vascular remodeling is much needed.
We propose a computational study that leverages our expertise in multiphysics simulations and cardiovascular
multiscale modeling toward maternal-fetal health applications. This project will focus on developing and
validating a novel computational framework that can simulate uteroplacental hemodynamics and critical
aspects of placentation and investigate the potential for applying these models to the early detection of
pregnancy complications. We will do this through the following Specific Aims: 1) Simulate uteroplacental
hemodynamics and determine the implications of spiral artery remodeling in the development of the placenta; 2)
Determine metrics to measure the risk of adverse placental development by combining standard-of-care
technology (Doppler ultrasound) and data from uteroplacental hemodynamics simulations.
Successful completion of this exploratory project will establish a modeling framework for the simulation of the
maternal-placental interface that would lay the groundwork for subject-specific modeling studies through an R01
award. More importantly, this model will offer a window into the early stages of pregnancy, which is currently
challenging to study in humans, and will help generate data to inform future hypothesis-driven — experimental
or computational — research.

Public health relevance
PROJECT NARRATIVE The short-term goal of this project is to develop and validate a computational model of uteroplacental hemodynamics to investigate pregnancy physiology. This computational model will generate new knowledge via simulations that can inform hypothesis-driven research. The long-term goal of the proposed computational framework is to augment available clinical data through computational simulations and, by doing so, provide new metrics for early diagnosis of pregnancy-related disorders and improve maternal-fetal health.